Metabolomics Technologies to Advance Biomedical Research

Project Summary
Metabolomics is a relatively new -omic technology experiencing exponential growth, and the opportunities
associated with it allude to its almost limitless potential. There are however numerous obstacles that limit
reaching its full potential. The development of bioinformatics tools such as XCMS Online, are needed to
streamline the process from raw metabolic data analysis to its interpretation. Some examples of further
development include the broad integration of data from orthogonal methods, autonomous metabolite
annotation and identification, which we have just begun to address within the XCMS Online and METLIN
platforms. Yet, perhaps the most interesting challenge is the identification of active metabolites using
metabolomics and systems biology strategies, an area of research that will have a profound effect on the
biomedical community. My overarching goal is not only to address these numerous obstacles, as we have a
track record of doing, but also to make our developments freely available and user-friendly and allow the entire
community and non-metabolomics experts from all fields (e.g. cancer, neurological disorders, diabetes,
virology, environmental exposure, and so on) to harness the enormous opportunity of metabolomics.
The funding will provide for the development of multiple connected strategic areas of metabolism-related
biomedical research in areas that represent key gaps in metabolomics including: autonomous metabolomics
data analysis, metabolite annotation and identification, metabolic guided system biology data integration,
identification of phenotype modulating metabolites and global cooperative quantitative mass spectrometry
analysis. As a part of the research described, it includes two junior faculty investigators (Lairson and Teijaro)
as collaborators whose expertise are in developing approaches for neurodegeneration treatment and
immunotherapy. For example, we will focus on identifying more potent metabolites to induce oligodendrocyte
precursor cells maturation!for the treatment of multiple sclerosis, identifying metabolites capable of improving
the immunological response in a T cell exhaustion model, to name a few. More broadly, our efforts will be to
continue facilitating biomedical research in general, in this we are uniquely positioned through our cloud-based
technologies, which currently serve over 22,000 registered users worldwide. The primary objective of our
efforts is to develop metabolomics to advance biomedical research.
Beyond developing the technology of measuring and analyzing metabolic data, correlating these
measurements with activity is one of our prime goals. Biomarker discovery, pathway analysis and systems
biology data integration, and cognitive computing are integral to the success of identifying metabolites that can
actively modulate the system, essentially fixing biology with biology. A result of this effort in the further
development of metabolomics is the underlying excitement, where, as technologists, we are no longer
simply passive observers but active participants in solving biomedical problems.
! 1!

Public health relevance
Project Narrative Metabolomics will play a key role in identifying metabolites that are mechanistically important and biologically active. We will create a metabolomics platform that will build upon our previous key technologies within the context of biomedical applications to identify biomarkers, characterize pathway and systems biology perturbations, and facilitate the identification of active metabolites. Our platform will provide insight into disease mechanisms, facilitate existing drug therapies, and identify novel endogenous metabolite therapeutics.